2012 Gamma Delta T Cell Conference

DESCRIPTION (provided by applicant): The fifth, biennial γδ T Cell Conference will be held on May 23-25, 2012 at the Hotel dei Congressi hotel and conference center in Rome, Italy. The goals of the conference are to bring together investigators from around the world working in γδ T cell biology to discuss unpublished results, develop new paradigms and directions for future research, highlight and encourage junior investigators, establish collaborations and facilitate sharing of resources. γδ T cells play unique roles in tissue homeostasis, response to infection, tissue repair, inflammation and tumor killing. Recent translational research studies and results from clinical trials demonstrate novel approaches to utilize γδ T cells for immunotherapeutic treatment of patients with a variety of malignancies. The International γδ T Cell Conference is held every 2 years and is the only forum for presentation and discussion of cutting-edge advances in basic to translational work that is focused on γδ T cells. Topics that will be covered in the conference include γδ TCR development and structure, antigens and ligands for γδ T cells, co-receptor and co-stimulatory molecules for γδ T cell function, specialized roles of γδ T cells in tissue repair and inflammation, function of γδ T cells in malignancy, infectious and autoimmune diseases, and immunotherapy with γδ T cells. Although the majority of the speakers will be selected from abstracts, commitments for participation have been obtained from the organizing committee, session chairs, discussion leaders and key speakers who are leaders in the field including women, minorities, and junior investigators. Funds are requested to provide support for travel awards for trainees and the invited speakers that are junior faculty. PUBLIC HEALTH RELEVANCE: γδ T cells play key roles in tissue homeostasis, inflammation, tissue repair, and antiviral responses plus they have potent anti-tumor activity providing support for clinical trials to determine if γδ T cells can be used for immunotherapy in various malignancies. The fifth, biennial γδ T Cell Conference will be held on May 23-25, 2012 at the Hotel dei Congressi hotel and conference center in Rome, Italy to provide a unique and exciting forum for discussion of the latest advances in the field.

Public health relevance
γδ T cells play key roles in tissue homeostasis, inflammation, tissue repair, and antiviral responses plus they have potent anti-tumor activity providing support for clinical trials to determine if γδ T cells can be used for immunotherapy in various malignancies. The fifth, biennial γδ T Cell Conference will be held on May 23-25, 2012 at the Hotel dei Congressi hotel and conference center in Rome, Italy to provide a unique and exciting forum for discussion of the latest advances in the field.